Phase 2 Study of Theophylline for the Treatment of Psuedohypoparathyroidism

PROJECT SUMMARY
Pseudohypoparathyroidism type 1A (PHP1A) is a rare, genetic disorder caused by impaired stimulatory
G protein (Gsα) signaling through downregulation of the gene, GNAS. PHP1A results in multi-hormone
resistance and early-onset obesity. The parent R01 (PI: Shoemaker, R01DK118407) is evaluating whether
theophylline decreases body mass index and improves glucose tolerance in PHP1A. As part of this clinical
trial, oral glucose tolerance tests and 6-minute walk tests are being evaluated to assess glycemia, insulin
resistance, and activity.
The overarching scientific goal of this supplemental study is to evaluate glycemia, activity, and sleep
using remote, wearable technology including continuous glucose monitors (CGM) and actigraphy. The primary
objectives of this study are to compare percent hyperglycemia on CGM, physical activity via actigraphy, and
sleep duration via actigraphy in individuals with PHP1A and matched controls. Secondary outcomes will
evaluate these “real-world” parameters with study assessments including OGTT and 6-minute walk tests.
The overarching career development goal of this study is to provide comprehensive training that will
enable the applicant to become an independent physician-scientist with a clinical and translational research
career focusing on insulin resistance and dysglycemia. The applicant will learn critical skills in human subjects’
research through both the completion of this study and the Master of Science in Clinical Investigation. She will
extend her understanding of metabolic parameters, learn to utilize remote monitoring devices in clinical
research, and gain expertise in human subjects’ research in rare diseases. This experiential and didactic
learning will be in conjunction with continued professional development, grant writing, manuscript writing, and
training in responsible conduct of research. The applicant’s primary mentor, Dr. Ashley Shoemaker, and
mentorship team are experts in glucose and insulin metabolism, the evaluation of activity, and clinical research
in rare diseases. They have provided the applicant exceptional mentorship thus far, while on the NIH F32
award (F32DK128970, August 2021). Vanderbilt University Medical Center (VUMC) provides an outstanding
research environment with abundant resources and training opportunities for young investigators.

Public health relevance
PROJECT NARRATIVE Pseudohypoparathyroidism is a genetic disorder with limited treatment options, characterized by early-onset obesity, short stature, and increased risk of type 2 diabetes. An ongoing clinical trial is testing if theophylline causes weight loss and improves glucose tolerance in pseudohypoparathyroidism. As a supplement to this trial, we will evaluate glucose levels, activity, and sleep using wearable, remotely monitored technology.